Developing an Inclusive Measure of Financial Hardship for People Living with Dementia and their Care Contributors

PROJECT SUMMARY
The number of individuals with Alzheimer’s disease or Alzheimer’s disease-related dementias (AD/ADRD) in
the U.S. is projected to increase to 9 million by 2030 (from 6.7 million in 2023). Approximately 1 million of these
individuals will identify as lesbian, gay, bisexual, transgender, queer, or another sexual or gender minority
(SGM). SGM older adults have fewer options for informal (unpaid) care as they are more likely be single, live
alone, and be kin-less, often relying on chosen care contributors—those who provide direct care or who
contribute financially to dementia care. SGM older adults also experience greater financial hardship than their
non-SGM peers due to disparities in earnings, fewer opportunities to build savings, and limited access to social
and legal programs. A diagnosis of AD/ADRD can not only be emotionally devastating for persons living with
dementia (PLWD) and their care contributors, but also financially devastating, as AD/ADRD is often cited as
the most expensive disease in the world, with the majority of the financial burden falling to PLWD and their
care contributors. As financial hardship is associated with worse mental and physical health outcomes and
lower health-related quality of life, SGM PLWD—who have been historically marginalized and already
experience disproportionate health and financial inequities—are at even greater risk for adverse
consequences. Taken together, SGM PLWD and their care contributors may represent a previously overlooked
priority population who are especially vulnerable to greater financial hardship and subsequent negative health
outcomes compared to their non-SGM peers, indicating the need to screen and prioritize interventions for this
group. However, no validated measures exist to assess financial hardship in the context of AD/ADRD nor
among SGM PLWD who may have unique support networks involving families of choice. This project will
address the need for an inclusive measure of AD/ADRD-related financial hardship (Inclusive Screener for
AD/ADRD Financial Expenses or I-SAFE) for use by care contributors to SGM and non-SGM PLWD.
Developing and psychometrically validating an inclusive measure of financial hardship in the context of
AD/ADRD will lay the groundwork for future intervention studies designed to reduce financial and health
inequities among SGM (an NIH-designated health disparities population) and non-SGM PLWD and their care
contributors. By incorporating one or more care contributors—which attends to the specific disease trajectory
of AD/ADRD—and expanding the concept of family to include non-kin care contributors, I-SAFE will further the
current measurement of financial hardship and be inclusive enough to capture the unique needs of SGM
PLWD and their care contributors. With projections regarding increasing numbers of older adults (SGM and
non-SGM) with AD/ADRD, growing diversity of the population, and rising costs of healthcare, this study has the
potential to make a significant impact on the lives of SGM and non-SGM PLWD and their care contributors.

Public health relevance
Public Health Relevance Statement The purpose of this study is to develop and validate an inclusive Alzheimer’s disease and Alzheimer’s disease-related dementia (AD/ADRD)-focused measure of financial hardship for use by a diverse population of care contributors to persons living with dementia (PLWD). A validated screener that is inclusive enough to capture the unique experiences of PLWD —without distinction of race, religion, political belief, economic or social condition—and their care contributors in the context of AD/ADRD, will help with the early identification of those at greatest risk of financial hardship and related negative physical and mental health outcomes. The increasing prevalence of older adults with AD/ADRD, the growing diversity of the population, and projections that AD/ADRD is becoming the most expensive disease in the world suggest that this project has the potential to make a significant impact not only on the lives of PLWD and their care contributors but may also contribute vital knowledge to inform future programs and policies.